Regulation of cardiac patterning via Akirin/NuRD Interactions

Project Summary
Congenital heart defects are the most prevalent birth defects in the human population, with an incident rate as
high as 10 in 1000 live births. A signiﬁcant number of these cases are termed sporadic, which are largely the
result of interactions between a number of independent genetic loci and alleles. To aid in our understanding of
the polygenic nature of congenital heart defects, it remains imperative to continue to identify new gene
regulatory partners that may play a role in the process of embryonic heart patterning. Our laboratory has
recently identiﬁed a cofactor, Akirin, that is responsible for interfacing transcription factor activity with chromatin
remodeling machinery to facilitate gene expression. Importantly, Akirin appears to play a role in the proper
patterning and morphogenesis of the embryonic heart in Drosophila melanogaster. Excitingly, our preliminary
data suggests that Akirin likely regulates insect embryonic heart development through interactions with the
CHD4/NuRD family of chromatin remodeling machinery. This mechanism of Akirin/NuRD interactions for
expression of cardiac developmental gene pathways appears to be conserved from mammals to insects.
To further determine the role of Akirin/NuRD interactions in the process of heart development, we propose two
speciﬁc aims: 1) Using a combination of genetic, biochemical, and live imaging techniques, will conﬁrm the
importance of Akirin/NuRD interactions during development, and 2) We will employ both next-generation
massively parallel RNA sequencing methods, as well as ATAC-seq and conventional chromatin
immunoprecipitation methods to determine the gene regulatory role of Akirin during cardiac myogenesis. This
work will provide key data for understanding the role of Akirin in the process of heart formation, and provide a
new avenue for studying and/or preventing causes of congenital heart defects.
Critically, in keeping with the goals of the AREA award mechanism, this project will give undergraduate
researchers hands-on experience in a wide variety of molecular, genetic, histological, microscopic, and
biochemical techniques, which will provide a valuable skill set for a future career in biomedical research.

Public health relevance
Project Narrative Heart defects in newborn infants remain the most prevalent form of human birth defect, yet the exact genes and genetic processes that can either positively or negatively aﬀect heart formation remain unknown. Studies on Akirin, a nuclear protein that is found in both fruit ﬂies and humans, have indicated that Akirin works with novel components of the gene expression machinery to enable the proper development of the heart. By studying the role of Akirin during this process in fruit ﬂy embryos, we will learn how this protein likely functions in vertebrates, such as mammals, during heart formation.